Metabolic regulation of osteoclast differentiation and bone resorption

Project Summary:
Glutamine is a conditionally essential amino acid that has myriad uses in the cell. Aside from direct
incorporation into protein, glutamine can be metabolized to generate nucleotides, other amino acids, the Krebs
cycle intermediate -ketoglutarate (KG) which is important for energy production and anabolic reactions, and
glutathione (GSH) to protect against oxidative stress. We recently determined that mature osteoclasts are
characterized by increased abundance of amino acids and nucleotides. Importantly, inhibiting glutamine
metabolism reduced nucleotide abundance and inhibited osteoclast differentiation. Unfortunately, the necessity
of glutamine metabolism to regulate osteoclast differentiation and bone resorption in vivo has not been
investigated. Moreover, how glutamine derived purine nucleotides mechanistically regulate osteoclasts
remains enigmatic. In this proposal, we will 1) establish the necessity and sufficiency of glutaminase (GLS)
dependent glutamine metabolism to regulate osteoclast differentiation and bone resorption, 2) evaluate the
efficacy of the GLS inhibitor Telaglenastat to inhibit bone bone resorption in the ovariectomy mouse model of
human osteoporosis, and 3) define the mechanisms by which glutamate oxaloacetate transaminase 2 (GOT2)
dependent purine biosynthesis functions downstream of GLS to regulate osteoclast metabolism and
differentiation. Our findings will have broad implications in understanding the roel and regulation of metabolism
during osteoclast differentiation and activity, bone homeostasis and pathological bone loss.

Public health relevance
Project Narrative: This proposal will be the first to inform upon the role of glutamine metabolism in osteoclast differentiation and bone resorption. Further, these studies will provide valuable insight into a potential new therapy for bone loss. Our findings will have broad implications in bone homeostasis and pathological bone loss.